RECOMBINANT HGH (SAIZEN) FOR HIV ASSOCIATED WEIGHT LOSS

The goals of this study is to evaluate the safety and efficacy of long term treatment with recombinant human growth hormone (Saizen) in the treatment of HIV-associated wasting and to determine if HIV-associated wasting can be reversed, leading to stable or increased body weight and functional capacity.